Administrative Core

The Administrative Core of the Mid-Atlantic Center for Cardiometabolic Health (MACCH) will be responsible for the overall administration of the grant, including guiding and coordinating shared data and intervention resources, Community Engagement Core and Investigator Development Core activities and supporting the three research studies. The overarching goal of MACCH is to test the effectiveness of comprehensive, integrated, and multi-level evidence-based strategies for improving cardiometabolic health outcomes among populations with unmet social and health needs, using community-based participatory research and patient-centered outcomes research principles, and translate them into clinical and public health practice. The Administrative Core, constituted of experts in Clinical Medicine, Nursing, Epidemiology, Biostatistics, Behavioral Science, Health Services Research, Implementation Science, and Community-Based Participatory Research, will be responsible for executing the overarching goal and assuring that the “whole [Center] is more than the sum of its parts”. The MACCH Administrative Core will build upon the strong existing administrative structure in the JHCHE, which has used a comprehensive approach to improve health outcomes that includes research and translation, education and training, community engagement, and local to global learning since 2010.